Geographic Access to Medication Assisted Treatment for Medicaid Enrollees with Opioid Use Disorder

Abstract
Medication assisted treatment (MAT) is an evidence-based treatment for opioid use disorder (OUD) involving
medication and behavioral therapy. Despite massive public expenditures to increase MAT access, MAT use
remains low. Limited geographic access to MAT is a key barrier to OUD treatment because MAT requires
frequent travel to providers. While expanding geographic access to MAT has been a policy priority,
policymakers lack reliable, accurate measures of geographic access to MAT to guide planning efforts. The
overall objectives of this proposal are to determine where and for whom geographic access to MAT is limited,
and to examine how geographic access to MAT affects OUD-related health outcomes. The hypotheses are
that geographic access to MAT is lower for disadvantaged socioeconomic groups, and that increased
geographic access to MAT improves OUD-related health outcomes. The rationale for this project is that
improved measurement of geographic access to MAT will enable policymakers to implement targeted, effective
interventions to increase MAT access and use. The applicant will use Pennsylvania Medicaid claims to
address the following specific aims: (1) Characterize variation in geographic access to MAT providers by car
and public transit; (2) Identify patient and environmental characteristics associated with geographic access to
MAT; and (3) Determine the impact of geographic access to MAT on MAT use and OUD-related overdoses.
This application is innovative because it will apply novel methods for measuring geographic access to MAT,
including disparities in access by public transit (which is particularly relevant to low-income populations in
Medicaid), and use these measures with causal inference methods to estimate the causal effect of geographic
access to MAT on OUD-related outcomes (including receipt of MAT and opioid overdoses). The proposed
research is significant because it will enable policymakers and researchers to accurately identify small
geographic areas where targeted interventions to improve geographic access to MAT are needed. It also will
estimate how effective such interventions would be. Ultimately, the proposed research will create an evidence
basis from which policymakers can prioritize interventions and allocate resources to efficiently increase
geographic access to MAT. Through a training plan developed with the support of a multi-disciplinary
mentorship team of NIH-funded investigators, this project will enable the applicant to develop a working
knowledge of the treatment of OUD and expertise in MAT policy and geospatial methods. This project also
places an emphasis on dissemination of results to state Medicaid administrators. Collectively, this project will
prepare the applicant to transition to independence by submitting a R01 application to NIDA examining how
various state policies affect OUD-related outcomes through their effects on geographic access to MAT.

Public health relevance
Project Narrative Policy makers recognize a critical need to expand access to medication assisted treatment (MAT) to address the opioid epidemic, particularly among underserved populations who may face difficulty traveling to a nearby provider. This project will implement novel methods for measuring geographic access to MAT, identify demographic groups and areas where geographic access to MAT is low, and examine the effect of geographic access to MAT on MAT use and opioid-related overdoses using Pennsylvania Medicaid claims. This project is relevant to public health because it will identify communities and populations where geographic access to MAT needs to be improved to address the opioid epidemic, and provide a rigorous analysis of the effects that improved geographic access can have on health outcomes, which is critical for guiding effective resource allocation to address the opioid epidemic.